Neuronal hyperexcitability and seizures in a Scn2a deficient mouse model

Project Summary/Abstract
Genetic studies in humans revealed that gain-of-function variants of SCN2A are associated with epilepsy,
whereas loss-of-function variants of SCN2A are associated with autism spectrum disorder (ASD). However,
about a third of ASD children carrying SCN2A loss-of-function or nonsense variants (collectively referred to as
SCN2A deficiency) develop intractable seizures, major comorbidity associated with ASD. How SCN2A deficiency
contributes to seizure is largely unknown. To address this problem, we generated a Scn2a-deficient mouse
model by gene-trap knockout (gtKO) strategy. Homozygous gene-trap knockout mice have only a quarter of the
Scn2a expression level of WT mice, which model severe Scn2a deficiency. Our preliminary patch-clamp
recordings reveal that neurons with severe Scn2a deficiency displayed neuronal hyperexcitability. This finding is
unexpected, but could open the door for the understanding of the puzzling seizure comorbidity in SCN2A
deficiency-related ASD. However, critical gaps exist regarding the possible mechanisms underlying Scn2a
deficiency-related neuronal hyperexcitability, its consequences on neural network and seizures susceptibility, as
well as the reversibility of seizures-related phenotypes. Filling these gaps would greatly enhance understanding
of the mechanisms underlying seizure comorbidity in ASD; and shed new light on the development of effective
therapeutic interventions. To this end, here we propose to test an overarching hypothesis that a substantial
reduction of Scn2a expression results in increased neuronal excitability related to K channel downregulation,
hypersynchronization of in vivo firing, and elevated seizure susceptibility that can be reversed by targeted genetic
interventions. We will test our hypothesis at the cellular, circuit, and in vivo levels. In Aim 1, we will assess ex
vivo neuronal excitability of Scn2a-deficient mice. In Aim 2, we will determine in vivo neuronal firings and seizure
susceptibility of the Scn2a-deficient mice. In Aim 3, we will test targeted genetic interventions. Our study is
significant in the following ways: i) SCN2A deficiency is among the leading monogenetic forms of ASD and
seizure comorbidity occurs in about 30% of affected ASD patients; ii) The finding that severe SCN2A deficiency
resulting in hyperexcitability is potentially paradigm-shifting, and the study of which could reveal key insights
regarding seizure comorbidity associated with ASD; and iii) Targeted genetic interventions to be evaluated have
clear translational relevance. Our study has the following innovations: i) the use of novel Scn2a deficient mice
that reveal unexpected finding of neuronal hyperexcitability; ii) innovative ways to achieve genetic rescue; and
iii) the use of cutting-edge technologies including high-density Neuropixels recordings. The applicant is an early
stage investigator (ESI), whose team has extensive expertise in sodium channel physiology, genetics,
electrophysiology, and pharmacology. The team is well suited to carry out the proposed work to its full completion
within the project timeframe, and generate impactful outcomes to advance the field.

Public health relevance
Project Narrative This project is relevant to NIH’s mission by providing fundamental knowledge regarding cellular and circuit basis underlying SCN2A deficiency-related neuronal hyperexcitability and seizures. Knowledge gained through the completion of this project provides a foundation for the development of novel therapeutic interventions to alleviate seizures in SCN2A related human disorders.